Interdisciplinary Visual Sciences (IVS) Training Program

The training and retention of the next generation of vision scientists was a major goal in the
2021 NEI strategic plan, with a stated mission to “Inspire and train a talented and diverse next
generation of individuals to expand and strengthen the vision workforce”. In line with this
mission, this T32 renewal application requests support to increase our Interdisciplinary Vision
Sciences (IVS) training program to four predoctoral and two post-doctoral positions annually for
years 16-20. Predoctoral trainees drawn from seven interdisciplinary graduate programs will be
supported for one year, extendable to two by fair competition annually. Postdoctoral trainees are
drawn from our preceptors’ laboratories. Our training plan includes multidisciplinary aspects of
the visual system, ranging from study of single molecules to the mechanisms underlying
ophthalmic diseases and cognitive processing of the visual input. All trainees take an intensive 3
credit semester long course “Biology of Vision” that is team-taught by faculty and IVS preceptors
and includes basis of grantsmanship and grant writing skills as a pathway to independence.
Training is supplemented with monthly meetings that encompass subjects ranging from science
communication, aspects of professional development, issues regarding rigor, reproducibility and
the responsible conduct of research, and the development of mentoring relationships. The plan
further details the exposure of trainees to a broader appreciation of basic vision research
through seminar series of invited speakers, faculty, and the trainees themselves. Every trainee
is required to present their scientific work at least yearly. Clinical exposure is also mediated by
requiring attendance to weekly UPMC Vision Institute Grand Rounds, and the annual ”Vision
Research Day” where all in Ophthalmology meet for a day of clinical and Basic research
discussions. The plan involves 18 preceptors with secured funding from three schools in two
universities that have a diverse range of vision science research programs. Preceptors receive
training themselves in the mentor-mentee relationship. Our program is the only vision training
program in Pittsburgh to offer a broad appreciation of vision science and the interdisciplinary
aspects of vision research. The past 10 years saw most IVS trainees succeed and remain in
research-intensive or -related careers in academia and industry. Several have subsequently
secured independent grant funding. We feel that this justifies the continuing T32 support from
the NEI so that we can add to the next generation of vision scientists and researchers.

Public health relevance
NARRATIVE Training a strong cadre of graduate students and postdoctoral fellows in vision research will guarantee a new generation of scientists who will study the visual system in health and disease. The IVS training program provides a multidisciplinary and rigorous understanding of the visual system, from eye to brain and from basic and translational perspectives, and graduates will forge novel approaches in advancing vision science and developing intervention and therapeutic frameworks.